Rapid assay to monitor vancomycin levels at the point of care in hemodialysis patients

SUMMARY/ABSTRACT
One in ten American adults suffer from chronic kidney disease, with over 425,000 end-stage renal disease
(ESRD) patients receiving hemodialysis (HD) on a regular basis. The risk of methicillin-resistant S. aureus
(MRSA) infections is 100-fold higher in HD patients, and septicemia is the second leading cause of death in this
population. The venous access site is the most common source of these infections, and due to the high
probabability of MRSA, it is common practice to empirically treat all suspected Gram-positive infections in HD
patients with vancomycin. However, vancomycin has a very narrow therapeutic index that must be closely
monitored. Vancomycin’s half-life increases from 6-12 hours in patients with normal kidney function up to 100-
200 hours in patients with impaired kidney function, with variable amounts of circulating vancomycin removed
by high-flux dialysis membranes during each HD session. Unfortunately, a trial and error dosing strategy remains
the standard of care for HD patients, and as a result, sub-therapeutic concentrations are found in up to 86% of
HD patients. This often leads to the emergence of vancomycin-resistant strains and an increased rate of
treatment failure. Thus, in order to maintain an effective circulating vancomycin concentration in HD patients,
clinicians need to shift to frequent serum measurements.
Competitive immunoassays are currently used to measure vancomycin levels in a central clinical chemistry
lab. While these approaches have sufficient sensitivity, they require specialized, expensive instruments and are
not in use at dialysis centers. Instead, dialysis patients receiving vancomycin have a blood sample drawn prior
to dialysis, which is then sent to a reference laboratory. Because the turnaround time for reference lab results
can be 48-72 hrs, patients are administered the next vancomycin dose prior to knowing whether or not levels
should be adjusted. This expands the duration of sub-therapeutic dosing by 2-3 days and fosters growth of
resistant bacterial strains in an already vulnerable host. To address this technical hurdle, Affinergy plans to
develop a point-of-care lateral flow assay that will enable frequent, low complexity, accurate and
affordable monitoring of vancomycin levels. Using our core technology of phage display biopanning, we have
already identified a proprietary capture peptide and detection reagent that bind with submicromolar affinity to
vancomycin. At the conclusion of Phase I, we will have a prototype lateral flow assay with established limits of
quantitation. In Phase II, we will scale up production of our assay, optimize performance characteristics, establish
storage conditions and determine stability. Finally, our assay will be validated in a dialysis patient population.
Successful completion of this project will lead to improved therapeutic efficacy for dialysis patients receiving
vancomycin.

Public health relevance
PROJECT NARRATIVE Vancomycin concentration must be closely monitored in patients with impaired kidney function. However, patients receiving vancomycin during outpatient dialysis must have blood samples shipped to reference laboratories prior to obtaining trough levels, leading to unacceptable delays in vancomycin dosage adjustment. In this Fast-Track application, we propose to develop a novel peptide-based sandwich assay to facilitate rapid, affordable, point-of-care measurement of vancomycin concentration in biological fluids.